Predoctoral Training Program in Genetics

Training Program in Genetics Summary
Genetics is a critical factor underlying human disease, wellness, and lifespan. Genetic research has led
to enormous improvements in the prevention, diagnosis and treatment of a great range of diseases. The long-
term objective of the proposed program is to strengthen the national scientific workforce to improve human
health. We have designed the Training Program in Genetics (TPG) to provide unified training in modern
genetics research for predoctoral students across three campuses and from three main departments at Yale
University. It aims to prepare PhD students for leadership positions in science and science-related careers via
five key objectives: i) to provide training in rigorous experimental design, new technology and quantitative
methods; ii) to build intellectual community among geneticists addressing a wide variety of problems and
across several departments; iii) to develop communication skills by providing opportunities to present research
and by providing feedback on the presentations; iv) to foster an environment that promotes diversity, equity,
and inclusion; v) to develop leadership skills that are applicable not only in genetics research but also in a
variety of other science and science-related careers. We will advocate for these innovations to be adopted by
other training programs and therefore impact the larger university community. Students develop skills via a
combination of coursework, laboratory research, and a rich variety of carefully designed program-specific
activities. The TPG will hold monthly Research in Progress talks, an annual Retreat, an annual Symposium,
workshops on R statistics and other topics, and opportunities to discuss topics in genetics with undergraduates
in a course for non-science majors. A number of career development opportunities will be provided. The TPG
is distinguished from other training programs at Yale by the remarkable wealth of interests of its trainers.
Faculty trainers are united by a common focus on genetics but address wide-ranging problems at different
levels in diverse species, providing exceptionally rich training. Junior trainers are mentored by senior trainers,
and all take a common evidence-based course on mentoring. Students and trainers are selected via a set of
criteria, including the diversity of background and experience that they bring to the program, as well as their
commitment to mentoring and supporting student education. The program will be overseen by two Directors
with complementary expertise, an internal Executive Committee, and an external Advisory Committee.
Success of the TPG will be evaluated regularly according to a detailed plan designed and executed by a
professional with expertise in program assessment. The program would welcome seven new students each
year and provide stipend and tuition support during years 2 and 3 for 14 slots total per year, with a cohort of ~
42 students across ~ six years of training.

Public health relevance
Project Narrative Human health and lifespan depend critically on genetics. Basic research on the principles of genetics can lead to dramatic improvements in the prevention, diagnosis, and treatment of a vast number of human diseases. The proposed program is designed to provide training in genetics research to predoctoral students and to prepare them for leadership in scientific research and research-related careers.